ASSESS L 748,731 IN PATIENT WITH OSTEOARTHRITIS OF THE KNEE

Investigate the safety and tolerability of continuous administration of a novel non-steroidal agent in patients with osteoarthritis of the knee.